Characterization of HCMV entry receptors

Project Summary Human cytomegalovirus (HCMV) is a ubiquitous b-herpesvirus that can infect individuals throughout the world. Primary infection results in acute low-level mononucleosis like systems followed by a lifelong persistent infection that can involve episodes of reactivation when the immune system is compromised leading to a number of diseases that include hepatitis, retinitis, pneumonitis, vascular sclerosis, as well as severe neurological disorders in neonates. Disease progression is undoubtedly enhanced by the ability of HCMV to infect a broad range of cell types including epithelial cells, endothelial cells, and monocytes. The ability of HCMV to infect these cell types is due to the presence of a glycoprotein complex on the virus envelope known as gH/gL/UL128-131 and evidence suggests that this pentameric protein complex specifically binds cellular receptors on these cell types during entry. However, to date, no receptors have been identified and this represents a major gap in the field. To that end, I have employed a novel cDNA library screen and identified CD147 as the first possible HCMV pentamer-specific receptor. The two specific aims of this project are to characterize the role of CD147 in entry into epithelial cells, endothelial cells, and monocytes as well as identify protein-protein interactions between CD147and the pentameric protein complex.

Public health relevance
Project Narrative Human cytomegalovirus (HCMV) infects nearly 80 percent of the world's population and causes significant morbidity and mortality. The current anti-viral agents used to treat HCMV infections are prone to resistance and can be highly toxic to patients and there is no current vaccine against HCMV available. The focus of this project will be to characterize a newly identified cellular receptor for HCMV that will have significant implications for understanding HCMV pathogenesis and serve as a novel target for developing new vaccines.